Career Enhancement Program

PROJECT SUMMARY
An increase in the number of investigators who possess the research knowledge and training from the bench to
the bedside is essential to the University of Wisconsin (UW) Prostate Cancer SPORE’s overarching goal to
advance translational research in prostate cancer. This Career Enhancement Program (CEP) provides an unique
collaborative structure and mechanism to cultivate the development of outstanding research careers for junior
faculty and mid-level investigators desiring to focus their careers towards translational research in prostate
cancer. Importantly, each trainee will have the opportunity to utilize cross-campus opportunities for research and
didactic training (e.g. NIH Clinical and Translational Science Award). The specific aim of the CEP is to provide
scientists and physician-scientists with integrated training and career enhancement support such that
they develop into successful, independently funded translational researchers and leaders in the field of
prostate cancer. Our goal is to produce future scientists, including physician-scientists, who will meet the great
need for innovation in methods to prevent and treat prostate cancer. The CEP will support up to four awardees
at any given time. Awardees will receive $50,000 per year for up to two years to support their research career
enhancement activities. The program boasts strong leadership, a wealth of expertise and resources, an
individualized clinical and scientific curriculum, and an exceptional pool of strong mentors and potential
applicants, and well-defined processes for recruitment and assessment harmonized across the institutions. The
CEP leverages institutional strengths across a large undergraduate and graduate campus that is ranked annually
in the top 10 of public research institutions to solicit submissions from such diverse departments as biomedical
engineering, pharmacy, nursing, medical physics, as well as the McArdle Laboratory for Cancer Research. This
also creates more opportunities to recruit applications from the Undergraduate Research and Mentoring Program
members in our entire campus community. The CEP will thereby foster the development of knowledge, skills,
professional attitudes, and experience required for successful academic careers in prostate cancer translational
research.